Validation and Kinetic Characterization of Blood-Cerebrospinal Fluid Barrier-Traversing Proteins in Aging With Library-Free Multiplexed Targeted Proteomics

PROJECT SUMMARY/ABSTRACT
The choroid plexus (CP) is a critical component of the blood-brain barrier (BBB), whose function is known to
degrade with aging. A better understanding of CP biology and how this biology shifts with age is a prerequisite
for utilizing the CP for blood-to-brain delivery of anti-aging drugs and may reveal new therapeutic targets in the
CP for age-associated diseases. One long-term goal of this project is to reveal how CP behavior, and transcytotic
protein transport from the blood to the cerebrospinal fluid (CSF) specifically, changes with aging. Technical
challenges inherent in this goal require new proteomic methods. Therefore, a second long-term goal of this
project is to bring proteomic technology, and targeted proteomics in particular, to a level where any set of
peptides can be detected and quantified with high sensitivity and dynamic range, even in challenging samples
such as CP and cerebrospinal fluid (CSF).
In my current work, I develop targeted proteomic methods based on the recently published GoDig targeted
proteomic technology, which enables simultaneous detection and quantification of hundreds of targets in up to
18 biological samples in a single run. I have submitted a manuscript to Journal of Proteome Research as a first
author describing a next-generation version of GoDig with much higher success rates, quantifying over 95% of
400 peptides. However, this method is still limited by the required pre-assembly of a data library, which is
infeasible to do with synthetic chemical labels and low-protein-amount samples such as mouse CP and CSF. I
have developed a new method using deep learning-based prediction to eliminate this requirement, resulting in a
method with superior flexibility and ease of use. In Aim 1, I propose to complete this method, using automatic
statistical scoring to ensure reproducibility (Subaim 1.1) and using theoretical spectra in place of deep-learning-
based spectrum predictions where necessary to enable library-free targeted proteomics of peptides with any
modification (Subaim 1.2), including those derived from the synthetic probes used in Aims 2 and 3.
Aims 2 and 3 describe using targeted proteomics to study blood-to-brain transport in aging. In Aim 2, I
propose to characterize the kinetics of blood-to-CSF translocation by several known and suspected CP-crossing
blood plasma proteins in young and aged mice. I will chemically label recombinant proteins, inject them into the
bloodstream, and then track their passage from blood to CSF by collecting CSF at various time points, enriching
the labeled peptides from the digested CSF, and performing targeted detection and quantification. In Aim 3, I will
study proteins on the CP surface, measuring the kinetics of movement from the blood-facing surface to the CSF-
facing surface, which occurs in transcytosis. I will use in vivo bioconjugation and click chemistry to create a
chemical “double label” that conclusively signifies this movement; this double labeling is a novel and powerful
strategy for studying protein translocation. Detection and quantification of the double label with GoDig will reveal
how the kinetics of transcytosis in the CP change with aging.

Public health relevance
PROJECT NARRATIVE It is known that blood-brain barrier function declines with aging, but the effects of aging on the choroid plexus, a key component of the blood-brain barrier that transports molecules between the blood and cerebrospinal fluid, are largely unknown. Measuring the extent to which blood-to-brain protein transport in the choroid plexus is altered in aging would reveal which transporters are best targeted as drivers of brain aging or as drug delivery vehicles. This proposal describes using novel mass spectrometry-based proteomic technologies to measure how the kinetics of translocation of transporters and cargo in the choroid plexus change with aging.